Comprehensive characterization of variants underlying heart and blood diseases with CRISPR base editing

Project Summary
How genomic variation influences cellular function is a fundamental problem with tremendous importance for
human disease. While it has traditionally been difficult to study the effects of specific sequence variants in an
experimentally controlled manner, precise genome editing technologies such as CRISPR base editing enable
“writing” of trait-associated variants to cells to unravel their function. In this proposal, we will perform multi-modal
genome editing-based functional characterization of a total of 72,000 genomic variants associated with
cardiovascular diseases (CVDs) and hematological traits. CVD and blood traits are uniquely suited to functional
dissection because cardiovascular (coronary artery disease, high blood pressure, dyslipidemia) and blood traits
have among the best-powered multi-ethnic GWAS of any traits, and a substantial component of trait variability
can be captured in cellular assays that can be scaled to perform high-throughput screening.
We have assembled an interdisciplinary team of world-class experts to provide a generalizable pipeline to
unravel the functional impact of CVD and blood trait variants by integrating: (1) rich and ancestry-diverse human
genetic discoveries, (2) broadly targetable CRISPR base editors and efficient delivery to primary human cells,
(3) high-content assays to profile phenotypes at the levels of chromatin, gene expression and cellular function,
and (4) computational methods to design, interpret, visualize, and share experimental results.
In Aim 1, we will employ a robust, three-tiered variant prioritization scheme that incorporates evidence for disease
association from large, multi-ethnic GWAS as well as probability of causality to nominate variants for functional
assessment. Through this scheme, we will select variants associated with red blood cell and neutrophil traits,
coronary artery disease, blood pressure, and HDL and LDL cholesterol that span a range of allelic frequencies
and likely causality to test in high-throughput cellular assays.
In Aim 2, we will perform systematic cellular phenotype-based screens using base editors to install candidate
variants as well as CRISPR epigenetic inhibition and activation to explore variant-containing regulatory elements.
We will use eight established, scalable cellular phenotypic readouts, each of which will enable us to assess
which of 12,000 variants and variant-centered elements alter CVD and blood trait-associated cellular
phenotypes. We will additionally employ a high-throughput, genome-integrated chromatin accessibility assay to
assess which variants alter chromatin accessibility in trait-relevant cell lines. We will follow up with targeted single
cell RNA-seq of 5,600 variants in primary cells from donors of different sex and ethnicity.
In Aim 3, we will produce a catalog of validated variants and their association with phenotypes for each of the
proposed screens. We will collaborate with other IGVF groups to utilize these data to optimize models that predict
functional variants, regulatory elements and disease-causing biological mechanisms, ultimately leading to more
complete understanding of the genetic underpinnings of cardiovascular and blood disease risk.

Public health relevance
Project Narrative Genetic variation dictates an individual’s risk of developing common ailments such as heart and blood diseases. Traditionally, it has been difficult to determine which of the millions of sequence variants influence disease susceptibility due to a lack of technologies that enable the causal assignment of genetic variants at scale. To address this unmet need, we will develop a generalizable pipeline that leverages technological breakthroughs in precise genome editing to unravel the functional impact of genetic variation on heart and blood disease risk, offering a rich catalog of the consequences of thousands of disease-associated variants that will be of broad utility to the Impact of Genomic Variation on Function (IGVF) Consortium and wider biomedical community.